Special Public T Cell Receptor Sequences that Predict Outcomes for Cancer Patients

Project Abstract
Despite the incredible diversity of potential T cell receptor (TCR) sequences, some are found widely in
the population; these are called "public TCRs" (pTCRs). There is a growing awareness that pTCRs
may sometimes play important functions; for example, they have been linked to long term control of
HIV. We have found 3 "special-pTCRs" (spTCRs) that are the subject of this proposal. As we show, the
presence of these spTCRs in the peripheral blood of cancer patients is highly associated with improved
progression free survival and overall survival in certain groups of patients. In this R21 proposal, we will
thoroughly interrogate the predictive power of spTCRs and characterize the cells that express them.
Specific Aim 1: To evaluate the prognostic value of spTCRs in diverse cohorts of cancer patients
receiving immunotherapy. We hypothesize the presence of spTCRs will be associated with improved
clinical outcomes in lung cancer, renal cell carcinoma and melanoma patients treated at our institution,
as well as patients treated on Cancer Immunotherapy Trials Network trials. We hypothesize that the
predictive value of these spTCRs will be highest in patients treated with checkpoint inhibitors.
Specific Aim 2: To identify the specificity and immunophenotypic features of spTCRs. Using a
combination of bead and flow-based cell sorting we will enrich spTCRs from PBMC for paired single-
cell TCR and RNA sequencing analysis to determine their phenotype and paired αβ sequence. Using
the αβ paired sequence, we will determine their specificities. By identifying the correct phenotype, other
cancer specific pTCRs may be identified for use as biomarkers or therapeutics.

Public health relevance
Project Narrative Humans have an incredible number of different T Cell Receptors (TCR) giving T cells their specificity; some of these, called "public TCRs," are shared in the population and may have important functions. We have discovered 3 special public TCRs whose presence in the peripheral blood of cancer patients correlates with progression free and overall survival. In this proposal, we will investigate the scope of predictive power for these special public TCRs and investigate their potential for therapeutic applications.